Brain MRI of Human Glaucoma

Abstract: Brain MRI of human glaucoma
Primary open angle glaucoma (POAG) is a leading cause of blindness, affecting 4 million Americans.
The disease starts with loss of peripheral vision followed by central vision. While elevated intraocular pressure
is thought to be a critical pathogenic mechanism causing retinal ganglion cell death, many glaucoma patients
continue to lose vision despite successful treatment to lower intraocular pressure. Here, we pursue a novel
hypothesis that pathological changes to the brain also occur in glaucoma, contributing to disease pathogenesis
and progression.
This hypothesis is based on our preliminary fMRI data showing that mild to moderate POAG patients
have functional remapping in the visual cortex. These preliminary fMRI data also show changes vary not only as
a function of peripheral to central visual field but also as a function of disease severity. Further, these functional
changes have structural correlates of gray- and white-matter degeneration in the brain visual pathways. More
effective treatment for glaucoma may require comprehensive strategies that target both the eye and the brain.
Our findings agree with prior histological evidence of concurrent neurodegeneration in the brain visual
pathway in glaucoma. In fact, some studies even show that structural damage in the brain visual pathway
precedes the loss of retinal ganglion cell fibers, suggesting neurodegeneration plays a role in this blinding
disorder. A few prior fMRI studies, stimulating only the central visual field, have reported overall reduced
stimulus-evoked activities in the visual cortex in glaucoma patients. However, it remains unknown to what extent
the peripheral and central visual function in the visual cortex is altered in glaucoma and how this functional
remapping relates to the progression of the disease.
Based on our preliminary data, we hypothesize that glaucoma leads to functional remapping of the visual
cortex as detected non-invasively by fMRI, and that more abnormal functional and structural neurodegeneration
from MRI predicts faster progression of visual field loss in patients at the same clinical stage of glaucoma. The
first aim of this study will determine functional and structural changes in the brain of glaucoma patients at different
stages of severity in a cross-sectional design. The second aim will elucidate how changes in the brain can help
to sub-stratify risk of clinical glaucoma progression in a longitudinal design. The translational impact will be
increased by comparing MRI findings with clinical eye exams that include intraocular pressure, visual field
perimetry, retinal nerve fiber layer thickness, and dilated fundus photography.

Public health relevance
There is recent preclinical and clinical evidence that patients with glaucoma, a leading cause of irreversible blindness, show early degeneration in the visual pathway of the brain, but it is unknown whether such degeneration precedes, coincides with, or follows clinical signs from fundus exams and of visual field loss. Lowering IOP, the only available treatment for glaucoma, may not be effective if the brain's visual pathway has already degenerated. Thus, imaging neurodegeneration in the visual pathway of the brain of glaucoma patients could provide insight into a unique aspect of glaucoma pathogenesis and point to adjunctive treatment strategies.